Role of microbially-derived metabolites in anti-tumor immunity in breast cancer

Summary
Bariatric surgery reduces breast cancer (BC) risk and improves therapeutic outcomes, but the mechanisms
underlying these benefits remain undefined. Critical discoveries by our group in the first five years of funding
provide support for the premise that microbially derived metabolites (MDM) mediate weight loss-associated
protection in BC. First, we demonstrated that MDMs including bile acids and branched chain amino acids (BCAA)
are changed by bariatric surgery-mediated weight loss, and these alterations are sustained over time. Second,
we published that mimicking primary bile acid signaling by repurposing an FDA-approved drug targeting bile acid
receptor FXR demonstrated reduced BC burden in a humanized mouse model. Third, through fecal microbial
transplant, we observed that circulating BCAAs were uniquely elevated by the post bariatric surgery gut
microbiome and associated with both reduced tumor burden and elevated anti-tumor Natural Killer T (NKT) cell
content. In fact, the transfer of gut microbiota from bariatric surgery weight loss mouse and human donors to
non-surgical recipient lean mice decreased tumor burden and improved effectiveness of αPD-1 immune
checkpoint blockade (ICB), demonstrating conserved benefits. However, the precise interactions between the
host-microbiome interactions, MDMs, and immune function in BC remain unclear and will be investigated in this
proposal. We posit that MDMs circulate systemically as signaling mediators to modulate immune homeostasis
and anti-tumor immunity. Our hypothesis is that improved anti-tumor immunity is mediated by MDM sensing,
which shapes anti-tumor immunity. Bile acid G protein coupled receptor TGR5 (GPBAR1) is highly expressed
on certain immune cells such as myeloid cells, but the role of immune-specific TGR5 signaling in BC anti-tumor
immunity is unclear. Aim 1 will evaluate TGR5 agonism as monotherapy or in combination with ICB therapy to
improve immunotherapy effectiveness. Gain and loss of function approaches will be used to investigate this
hypothesis, including pharmacologic TGR5 agonism and antagonism, TGR5 null mice, and immune-depletion
studies to assess TGR5-dependent signaling in anti-tumor immunity and its role in improved ICB outcomes in
complementary models in ER+ and ER- BC, as well as organoid culture. Aim 2 will elucidate the role of BCAA
in BC through NKT cell activation. We show that BCAAs correlate with reduced tumor burden and elevated NKT
cell content in BC. Primary and metastatic BC models will be used to test BCAA impacts on ICB in multiple BC
subtypes, accompanied by in vitro approaches to define BCAA-NKT cell interactions using supplementation,
deficiency, and pharmacologic approaches. Effectiveness of the mono/combination therapy will be determined
by tumor progression, metastasis, high dimensional flow, and state-of-the-art single cell and spatial
transcriptomic analyses. Our team’s expertise in the “immuno-oncology-microbiome” axis will delineate important
host-microbe interactions. In sum, this proposal will discern a role for MDMs in BC through repurposing TGR5
agonists for therapy and initiating BCAA supplement to improve ICB effectiveness.

Public health relevance
Narrative Our goal is to identify mechanisms underlying the long-lasting anti-cancer protection associated with a history of bariatric surgery which reduces cancer risk, improves therapeutic outcomes, and increases survival in breast cancer patients. One mechanism may be through improvements in the types of microbes that inhabit our gut and produce metabolites or biochemicals to signal both locally and systemically to boost immune cell function. This project will identify and test the effect of microbially-derived metabolites on anti-tumor immunity with the aim to discover novel combination therapies to improve outcomes for breast cancer patients.